Spatial transcriptomics at the interface of implanted electrodes in the brain

PROJECT SUMMARY
Through “read-out” and “write-in” of electrical activity, implanted electrodes in the brain have enabled new
discoveries in basic neuroscience research and breakthroughs in the treatment of neurological diseases and
injury. However, the biological response to electrodes is widely believed to contribute to variations in recording
and stimulation efficacy over time. Despite decades of research, it remains unclear which elements of the tissue
response are performance-determining, as traditional metrics of the tissue response have failed to fully explain
changes in signal quality, stimulation thresholds, or device longevity. It is our objective to explore new hypotheses
and apply new methods to this long-standing issue. In this proposal, we will apply state-of-the-art techniques in
spatial transcriptomics to the device-tissue interface. This approach will build upon our recently reported
publication, which described spatiotemporal changes in gene expression surrounding devices using a
combination of laser capture microscopy and RNA-sequencing. The data revealed 157 differentially expressed
(DE) genes in tissue surrounding implanted electrodes in comparison to unimplanted control tissue. However,
spatial transcriptomics detects the spatial distribution of transcriptional changes in tissue via barcoded RNA-
capture oligonucleotides mounted to slides. The method delivers several advantages over previous approaches:
(1) superior spatial resolution, (2) excellent RNA quality, and (3) the ability to assess transcriptional changes in
combination with traditional immunohistochemistry labeling within the same tissue slice. Recently, we
successfully applied spatial transcriptomics to rat motor cortex tissue following implantation of a single electrode
array for a period of one week. The preliminary data revealed superior spatial sampling of transcriptional changes
as well as newly unmasked DE genes. The purpose of this R03 application is to collect a more comprehensive
pilot data set to explore these changes across multiple animals and time points (2 hours to 6 weeks), while
developing analysis techniques to reveal novel gene modules expressed in tissue local to devices. The study
includes two aims: Aim 1 will reveal the spatial organization of transcriptional changes surrounding implanted
electrodes in the motor cortex of rats across a six-week time course and Aim 2 will develop network analysis
techniques to reveal device-induced gene modules and key hub genes localized to the implant interface. We
expect the project to deliver a novel data set which will be useful to the field as a stand-alone effort (all data and
codes will be publicly accessible), while providing a foundation for future follow-on studies in a larger-scale
proposal.

Public health relevance
NARRATIVE The use of implanted electrodes in the brain is rapidly expanding, creating new opportunities to understand normal brain function and treat neurological diseases and injuries. The foreign body response to these devices has posed a long-standing challenge to stable, long-term recording and stimulation performance. We seek to apply a new technique, spatial transcriptomics, to the device-tissue interface to provide a novel view of the spatiotemporal profile of transcriptional changes surrounding implanted electrodes.